Musculoskeletal Adaptive Platform Trial (MAPT)

ABSTRACT
Over 1 million Americans undergo surgical treatment for a fracture each year. Despite advances in clinical
research over the past few decades, poor outcomes remain unacceptably common in this population. The
conventional clinical trial design remains slow, inefficient, and unmalleable to a changing clinical landscape.
Adaptive platform trials have emerged as a highly efficient alternative, enabling the simultaneous comparison
of multiple interventions under the same infrastructure and the addition of new interventions after trial initiation.
However, to realize these efficiency gains, substantial pre-trial planning is required. Our trial’s study population
will broadly include patients 65 years or older admitted with a fracture of the lower extremity, pelvis, or
acetabulum. We will focus on comparative effectiveness interventions and have a roster of comparisons ready
to launch once the platform is developed. The comparisons can apply to the entire study population or a
specific therapeutic domain, defined as a subpopulation for a decisional dilemma exists, and the interventions
will be compared (e.g., plate vs. IM nail in patients with a distal femur fracture). We will assess all comparisons
using the win ratio approach four months after randomization based on a common hierarchical composite
endpoint of death, ambulation status, and days at home. To successfully initiate this adaptive platform trial, we
propose an 18-month planning period. In that time, we will leverage our team’s experience designing,
implementing, and conducting multicenter trials in orthopaedics and adaptive trials in other areas of clinical
research. During the planning period, we will complete the following three specific aims: 1) perform computer
simulations to determine adaptation parameters, 2) establish stakeholder groups and structure for determining
the sequence of research comparisons and therapeutic domains, and 3) establish clinical trial infrastructure for
the platform.

Public health relevance
NARRATIVE Despite tremendous progress in improving the quality of orthopaedic trauma research over the past decades, poor outcomes remain unacceptably common in this patient population. The adaptive platform trial design has emerged as a highly efficient alternative to the conventional randomized clinical trial design, allowing multiple interventions to be simultaneously compared with sample sizes adapted to yield clinically actionable inferences. We propose an 18-month planning period to support the pre-trial simulations, document development, and trial structure to initiate a comparative effectiveness adaptive platform trial aimed at improving patient-important outcomes of patients 65 years or older with a lower extremity fracture.